C. elegans Gastrulation: a Model for Understanding Apical Constriction Mechanisms

Abstract
Apical constriction is a change in cell shape that drives critical morphogenetic events, including gastrulation
and branching morphogenesis in diverse animals and neural tube formation in vertebrates. Fundamental
questions about mechanisms of apical constriction remain unanswered. Research in this laboratory focuses on
understanding how cells accomplish this change in shape. Apical constriction is being studied to uncover
insights into how animals are shaped, and to contribute to a foundation of basic science leading to improved
diagnosis and prevention of neural tube defects. This proposal will support projects to answer how the
molecules that contribute to apical constriction generate and transmit the forces that change cell shapes, how
a cell’s actin architecture is dynamically altered, how developmental patterning mechanisms deploy cell
biological players with the necessary spatial and temporal precision, and how novel mechanisms contribute to
apical constriction. The laboratory has developed technical innovations to address critical barriers to progress
in this field, and the proposed projects build on the lab's strength in dissecting cell biological mechanisms of
development more generally. Study of apical constriction intersects with some of the major themes in cell and
developmental biology including cell polarization, control of motor activity, and dynamic control of forces, in a
complex in vivo context. The proposed projects seek to combine in a single model system the tools that are
valuable to different model systems, plus the new tools that the lab has developed, to produce unique and
sustained contributions to unraveling mechanisms that are relevant to critical morphogenetic events.

Public health relevance
Narrative Neural tube defects (spina bifida and anencephaly, for example) constitute the second-most common class of birth defects, resulting in significant suffering and monetary costs: ~$1 billion total in hospitalization costs for all US patients annually. This proposal seeks to understand mechanisms of apical constriction, a change in cell shape that contributes to successful neural tube closure, using C. elegans as a model for efficient investigation of cellular and molecular mechanisms. The long-term goal of the work is to understand fundamental mechanisms that can lay a foundation for future diagnosis and prevention of neural tube defects.